Maintenance of the tRNA 3' end

in instruction on page 6. Appendix (Five collated sets, No page numbering necessary for Appendix.) Number of publications and manuscripts accepted or submitted for publication (Not to exceed 10) 2 __ Appendix 1: Hou, YM. (2000) "Unusual synthesis by the Escherichia coli CCA-adding enzyme", RNA 6, 1031-1043. Appendix 2: Seth, M, Thurlow, DL, Hou, YM. (2002) "Poly(C) synthesis by class I and class II CCA-adding enzymes", Biochemistry 41, 4521-4532. Letters of support (two), one each from Dr. Christine Chow and Dr. Ming-Daw Tsai. PHS 398 (Rev. 5/95) (Form Page 4) Page 2 EE Number pages consecutivelyat the bottom throughout the application. Do not use suffixes such as 3a, 3b.